Prescribing Cascades among Nursing Home Residents with ADRD

PROJECT SUMMARY
Polypharmacy, usually defined as the concurrent use of five or more medications, occurs in over 90% of nursing
home (NH) residents with Alzheimer’s Disease and Related Dementias (ADRD). Prescribing cascades are a key
driver of inappropriate polypharmacy. A prescribing cascade occurs when adverse events from one medication
(the “precipitant medication”) are misinterpreted as manifestations of a new medical condition, resulting in the
addition of another unnecessary medication to manage symptoms (the “resultant medication”). Because the
underlying cause of the adverse event is never resolved and a new medication with additional risks is started,
prescribing cascades may result in adverse outcomes such as hospitalizations, injurious falls, decreased
physical and cognitive function, and death. Our research team’s preliminary data suggest over 50% of NH
residents may experience prescribing cascades. There is a severe lack of evidence on the causal effects of
prescribing cascades on health outcomes in NH residents, especially those with ADRD, who are at high risk of
polypharmacy and its adverse effects. To optimize prescribing and deprescribing, it is essential to generate
evidence on prescribing cascades and their effects among NH residents with and without ADRD. Without
additional evidence, providers will be unable to identify clinically significant prescribing cascades that could be
intervened on to improve NH resident health outcomes. Thus, the overall objective of this proposal is to
understand how prescribing cascades arise in NH residents and to quantify their effects on outcomes. Our central
hypothesis is that prescribing cascades increase the risks of adverse health outcomes (e.g., hospitalizations,
decreased physical function, fall-related injuries, mortality) and the risks will be greatest among residents with
severe cognitive impairment. This hypothesis will be tested through three specific aims: Aim 1, Identify risk
factors for clinically relevant prescribing cascades among NH residents with and without ADRD; Aim 2, Estimate
the effect of precipitant medication use on subsequent resultant medication use among NH residents with and
without ADRD; and Aim 3, Quantify the effects of the prescribing cascades on adverse outcomes among all
older adults in NHs and those in high-risk subgroups. To accomplish the proposed aims, we will leverage a large
innovative database of NH electronic health record information linked to national Minimum Data Set clinical
assessment records, Medicare health insurance claims, and other relevant datasets. We will also innovate by
developing the use of novel causal inference approaches, including sequential target trial emulation and doubly
robust estimation methods, for studying prescribing cascades and other related exposures. The proposed
research is highly significant because it will provide clinically actionable empirical evidence to help guide the
prescribing, deprescribing, and management of medications to minimize the risk of important prescribing
cascades and adverse outcomes among NH residents with ADRD. This proposal is directly responsive to PAR-
22-093 and advances the National Institute on Aging’s Strategic Goal C to improve the safe use of medications.

Public health relevance
PROJECT NARRATIVE Prescribing cascades are an insidious type of suboptimal medication prescribing that occurs when adverse events from one medication are misinterpreted as symptoms of a new medical condition and result in the addition of a new unnecessary medication, thereby predisposing patients to additional adverse events and major harms. This research will identify important prescribing cascades and rigorously examine their effects on health outcomes in older nursing home residents with Alzheimer's Disease and Related Dementias. Study findings will provide evidence that directly informs medication prescribing, deprescribing, and management to improve the safe use of medications among nursing home residents with Alzheimer's Disease and Related Dementias.